Administrative Core

SUMMARY: The Administrative Core (Core A) will continue to provide the mechanism and structure to plan,
evaluate, and manage the four Projects and two other Cores in this Program Project (PPG). The goals of Core
A are to provide scientific, programmatic, and fiscal leadership and facilitate communication between all
researchers to ensure that the Projects fulfill the goals set forth in the proposal and meet the administrative and
financial requirements of the NIH, the University of Rochester, and the two other institutions involved, Harvard
Medical School in Boston, and the Albert Einstein College of Medicine in New York. Core A will facilitate monthly
meetings by videoconference and annual face-to-face meetings. The Core will also be responsible for the
communication between the PPG and the NIH. Further, the Core will ensure that the results of each Project are
disseminated in a timely manner for the benefit of the scientific community. To this end, Core A will facilitate the
submission of joint publications and, in collaboration with Core C, will maintain a database for all biological
specimens and data generated by the Projects and Cores. Finally, Core A will organize the biennial reviews by
the external Scientific Advisory Board.